Core H: Down Syndrome Cohort

Core H: Down Syndrome Core
Project Summary/Abstract
Since its inception, the UC Irvine Alzheimer Disease Research Center (ADRC) has included people with Down
syndrome (DS) as a central focus of its research mission. Because of the triplication of the APP gene on
chromosome 21, individuals with DS accumulate amyloid in the brain over the lifespan. This places people with
DS at substantially increased risk for dementia. Yet, the age of symptom onset is variable and there is need for
increased understanding of the temporal sequence of events in the AD pathogenesis as well as factors that
precipitate dementia and protect against it. This application represents the launch of an independent DS Core
in the ADRC, an exciting development that will increase opportunities for the study of DS and AD at UCI and
beyond. Establishing a DS Core will facilitate interactions between this and other ADRC Cores, especially new
cores being initiated, such as the Biomarker Core, and will enhance opportunities for data sharing. The DS
Core will continue to engage in longitudinal research. The Core will expand the population enrolled, including
participants as young as 18 years of age, to better elucidate the earliest possible stages of disease. Special
emphasis will be placed on developing tools to facilitate multisite DS research, including clinical trials. As
always, the expert investigators studying the DS and AD will contribute their unique expertise and experiences
to training the next generation of clinicians and scientists. The DS Core will continue to provide unique insights
into the understanding of AD.